Small molecule therapeutics for myotonic dystrophy type 1

Summary
Myotonic dystrophy 1 (DM1) is an autosomal dominant disorder resulting from the expansion of a CTG
repeat tract in the 3’ untranslated region of the DMPK gene. The primary therapeutic target in DM1 is the
mutant DMPK RNA encoding expanded CUG repeats (CUGexp), which forms toxic intra-nuclear
aggregates or CUGexp foci in patient cells. We have developed an RNA-based screening strategy to
identify small molecules that selectively modulate the DMPK CUGexp RNA without affecting the normal
DMPK transcript. In a pilot screen of 2,500 compounds we identified a prototype small molecule MDI16,
which effectively reverses critical DM1 pathological features in both patient cells and in the HSALR mouse
model of DM1. As identification of multiple leads greatly enhances the probability of a small molecule
therapy for DM1, we used this screening strategy to identify 30 novel hits from 40,000 diverse drug-like
small molecules of the MSSR-UCLA library, which has undergone extensive filtering against liabilities. This
panel of hits show better safety and efficacy in reducing CUGexp foci when compared to MDI16 in patient
cells. Importantly, comparative analysis demonstrates that our hits perform on par with antisense
oligonucleotides directed against CUGexp and better than DM1 small molecule therapeutics published in
the literature. In this application we propose to identify lead compounds by rank-ordering the efficacy,
potency, selectivity and safety of our hit panel in reversing key DM1 pathological features including the
formation of CUGexp foci, aberrant RNA splicing, SHARP mis-localization, elevated CUGBP1 and GSK3b
levels in DM1 patient myoblasts. Biochemical assays will be used to determine the mechanism of action
of top-ranked hits, which will be tested for their in vivo efficacy in reversing DM1 skeletal muscle disease
in the HSALR DM1 mouse model. Blood brain barrier penetrance of the hits will be tested in a novel bi-
transgenic mouse model that expresses CUGexp foci in the brain. As there is no effective treatment for
DM1, the identification of candidate therapeutic compounds offers hope for patients with this debilitating
disease.

Public health relevance
The identification of candidate drugs that halt or slow down the progression of Myotonic Dystrophy Type 1, a genetic disorder with no cure, is urgently needed. This project seeks to identify novel potent chemical compounds of therapeutic value for this disease.